Georgia Clinical & Translational Science Alliance (GaCTSA)

Contact PD/PI: Taylor, W. Robert Admin-Core-001 (377) Project Summary / Abstract - Administrative Core The Administrative Core will provide structure to the Georgia Clinical & Translational Science Alliance (GaCTSA), evaluate GaCTSA's efforts, and use that data to continually improve performance. To meet these goals, the Administrative Core will: 1) Provide leadership, structure and organization, governance, and communication support to enable GaCTSA to fully capitalize on unique and complementary strengths of the academic, healthcare, and development partners of the GaCTSA, 2) Coordinate the reporting of data across Cores, Functions, and collaborating institutions; enhance existing informatics systems and analytics to improve metric collection; build innovative data systems and survey methodologies; disseminate evaluation reports to GaCTSA leadership and oversight committees; and adopt and develop innovative evaluation metrics and techniques (including the new Common Metrics) to produce a comprehensive, data-rich assessment of GaCTSA impact throughout Georgia, and 3) Commit to improving quality of clinical and translational research by enhancing existing institutional infrastructures to ensure participant safety and ethical human subject research, then applying a systematic approach to maximize the efficiency of operations and distribute that knowledge across the partner institutions. Project Summary/Abstract Page 629 Contact PD/PI: Taylor, W. Robert Admin-Core-001 (377) OMB Number: 4040-0001 Expiration Date: 06/30/2016 RESEARCH & RELATED Senior/Key Person Profile (Expanded) PROFILE - Project Director/Principal Investigator Prefix: First Name*: W. Middle Name Robert Last Name*: Taylor Suffix: M.D. Position/Title*: Professor of Medicine Organization Name*: Emory University Department: Division: Street1*: Cardiology Division Street2: Emory University City*: Atlanta County: State*: GA: Georgia Province: Country*: USA: UNITED STATES Zip / Postal Code*: 303220000 Phone Fax Number: 404-727-3585 E-Mail*: [email] Number*: 404-727-8921 Credential, e.g., agency login: BKKMCTM Project Role*: Other (Specify) Other Project Role Category: Core Lead Degree Type: MD,PHD,BA Degree Year: File Name Mime Type Attach Biographical Sketch*: Attach Current & Pending Support: Page 630 Tracking Number: GRANT12172810 Funding Opportunity Number: PAR-15-304 . Received Date: 2016-05-25T16:47:02.000-04:00